The BLSA Home Visit Program

Activities conducted within the context of this project include: 1. Make a telephone contact with eligible BLSA participants to establish current status and williness to attend a BLSA clinic visit, participate in the home visit program or complete a telephone interview. 2. In BLSA participants enrolled in the home visit program, conduct an extensive assessment of health status, aimed at ascertaining multiple health-related outcomes (cognitive impairment, dementia, mobility limitation, ADL disability, frailty, fatigability and major health conditions including CHD, cancer, etc.). 3. In BLSA participants enrolled in the home visit program, collect a blood sample to be used for basic tests of clinical chemistry and storage of cells, serum and plasma. 4. Provide participants and their families with a detailed description of the study, and obtain informed consent for participation, including consent for the use of biological specimens. 5. Create a database with tracking information and all information collected over the telephone interview and during in person home visits, maintaining full compatibility with the BLSA core database. 6. Conduct an interim survey administered over the phone or sent by mail to collect data related to COVID-19 exposure and symptoms and impact of the pandemic and its consequences on daily life, feelings of isolation, health-related behaviors, social interaction, personal finances and the like.